Defining Molecular Epitopes of Protective Antibodies to Flaviviruses

Project Summary/Abstract:
The objective of this K08 Mentored Clinical Scientist Career Award Application is to provide Dr. Alena Markmann
with a strong foundation in human immunology and the latest methods for studying human immune cells before
launching her independent research career on the human immune response to RNA viruses. Dr. Markmann is
an Assistant Professor of Medicine, tenure track, at the University of North Carolina -Chapel Hill (UNC) School
of Medicine with a joint appointment in the Department of Microbiology and Immunology. The candidate has
expertise in and a strong track record of publications on antibody structure, antibody-antigen interactions and
antibody neutralization of viruses. By strengthening her knowledge of adaptive immunity to RNA viruses and
mastering the latest methods for analyzing antigen specific B cells, Dr. Markmann will study how the human
immune response to emerging flaviviruses like dengue and Zika can suppress viral infection and disease or
enhance viral replication and exacerbate disease. The candidate and her mentor Dr. Aravinda de Silva have
designed a training plan that includes a rigorous research component along with didactic instruction, networking
and presentation opportunities, team management skills as well as manuscript writing and grantsmanship.
Together these skills will establish the methods and principles necessary for successful career development.
Flaviviruses are enveloped positive stranded RNA viruses that pose a growing threat to the human population
and cause millions of infections annually. They are vector-borne, transmitted by ticks and mosquitoes, and cause
a spectrum of disease manifestations including febrile illness, encephalitides that can cause lifelong
complications, Congenital Zika Syndrome and dengue hemorrhagic fever and shock syndromes. For the most
part, flaviviral infection result in a neutralizing protective antibody response against the infecting virus, that can
last for years after infection. The four dengue viruses however are very similar antigenically and in many cases,
result in generating a broad cross-neutralizing antibody responseto dengue virus serotypes that individuals have
not yet been exposed to. Thus far, no one has identified the viral target site of these broadly neutralizing dengue
antibodies that exist in the serum. Furthermore, though we know of a few major targets of the Zika protective
antibody response from studying memory B cells, we do not know what the serum targets are. Preliminary results
suggest that in the case of Zika serum antibody responses, binding targets are correlated with known strongly
neutralizing memory B cell-derived antibody targets. Thus, we hypothesize in Aim 1, that serum antibody
responses will mirror memory B cell responses, but will likely come from a smaller number of B cell clones and
be less cross-reactive with other flaviviruses. In Aim 2 we will identify the viral binding targets of broadly cross-
neutralizing dengue antibodies from the serum. These studies will result in the ident ification of critical protective
viral targets to both dengue and Zika viruses from the serum antibody compartment in order to inform successful
vaccine design.

Public health relevance
Project Narrative This application proposes to isolate neutralizing monoclonal antibodies from the plasma of Zika virus recovered individuals that have been generated from long-lived bone marrow plasma cells, and for the first time, compare the lineages and viral targets of B cell generated antibodies from both circulating and marrow compartments. In addition to this novel work with Zika virus, this proposal will identify broadly neutralizing dengue virus antibodies from the plasma of individuals infected with two different dengue viruses which will inform vaccine design and have the potential to be developed as pan-dengue therapeutics. This award is thus primed to identify a potential paradigm shift in our understanding of the mechanisms by which human B cells develop, mature and respond in acute viral infections.